MALLIARD REACTION OF ASCORBATE W/ LENS PROTEINS : AGING: DIABETES

One objective is to elucidate the chemical mature of posttranslational modification of lens proteins in aging and cataract formation. The sugar-mediated modifications are being studied. A second objective is to develop methods to inhibit the formation of modifications with the objective of delaying or inhibiting cataract formation